Molecular Mechanisms of TRAF7 Mutant Aggressive Meningiomas

PROJECT SUMMARY / ABSTRACT
Meningiomas are the most common primary brain tumors. While typically of benign histology, they can be
associated with significant neurological morbidity and have the potential for malignant transformation. In our
previous studies, we completed genomic analysis of over 700 meningiomas using whole exome and targeted
next-generation sequencing, identifying driver mutations in 12 genes and establishing mutually exclusive
molecular subgroups. We now propose to investigate the molecular mechanisms underlying the formation of
TRAF7-dependent meningiomas (which represent up to one quarter of all meningiomas), undertake
molecular genomic analyses to identify somatic coding and non-coding or genomic events in TRAF7 tumors
that progress to higher grades. We also propose to test and validate candidate drug efficacy using primary
cultures from surgically resected meningiomas carrying TRAF7 aberrations, as well as mouse models of
meningioma that we have established.

Public health relevance
PROJECT NARRATIVE Meningiomas are the most common brain tumor and are usually benign, but because they cause neurological deficits by compressing brain structures, they are treated surgically or with radiation. The proposed research is relevant to public health because understanding the genomic architecture of meningiomas will provide the necessary background to test the response of these tumors to targeted drugs.